Body Heat Content and Dissipation in Obese and Normal Weight Adults

Our work over the past year has been in collaborative support of NICHD protocol 06-CH-0038, "Body Heat Content and Dissipation in Obese and Normal Weight Adults". Activities included the study of core body temperature using wireless temperature-sensing capsules. We learned that mean (SE) daily core body temperature did not differ significantly between the 35 nonobese and 46 obese subjects (36.92 0.03C compared with 36.89 0.03C;P = 0.44). Core temperature 24-h profiles did not differ significantly between 11 normal-weight and 19 obese subjects (P = 0.274). Women had a mean core body temperature 0.23C greater than that of men (36.99 0.03C compared with 36.76 0.03C;P <0.0001). We conclude obesity is not generally associated with a reduced core body temperature Several methods, including infrared imaging and thermo-patch technology, to identify thermogenic brown fat depots in the supraclavicular region of the human subjects were further developed.